Personalized spatiotemporal hemodynamic response models for functional magnetic resonance imaging

Functional Magnetic Resonance Imaging (fMRI) shows great promise in characterizing
brain circuits and networks related to human mental function and identifying
pathophysiological changes underlying mental health disorders, healthy and pathological
aging, substance misuse, and beyond. Great strides are being made in many areas, but
the vast majority of fMRI research relies on the simplifying assumption of a canonical (or
highly constrained) hemodynamic response function (HRF) that is substantially
inaccurate. The HRF varies across brain regions, individuals, and age, but estimating it
with sufficient accuracy and precision is problematic in small to medium-sized studies.
As a result, over 95% of fMRI studies use a canonical HRF of fixed form. This results in
substantial bias, power loss, and confounding. These problems apply to both task-based
and connectivity studies, which rely implicitly on the assumption of a constant HRF
across regions and individuals. In response to the “Notice of Special Interest (NOSI)
regarding the Use of Human Connectome [HCP] Data for Secondary Analysis”,
propose to use the Lifespan
aged 5-100) combined with advanced statistical modeling t
we
HCP data (n=~3,600 high-quality datasets from people
o address this issue. In Aim
1, we will contrast commonly used HRF models across the lifespan based on reliability
and ability to ‘decode’ task state and phenotypic variables (e.g., cognitive function and
mood). We develop novel methods for extracting meaningful phenotypic information
from HRF shape and population inference, and develop robust software for best-in-class
models. In Aim 2, we integrate best-in-class HRF models into a novel Gaussian process
model and use it derive a demographic-specific, spatiotemporal HRF atlas, providing
customized HRFs based on readily measurable characteristics (age, sex, and body-
mass index) and brain region. In Aim 3, we use the HRF atlas to deconvolve rs-fMRI
data and construct an HRF-corrected connectome map. We validate the HRF models,
atlas, and connectome on two independent HCP Disease Connectomes and the CAM-
CAN dataset (n=~700), and share the atlas, connectome, and software integrations with
the research community. The development of these large-sample models will provide
more accurate and precise estimates of task-related fMRI activity and connectivity in
basic and clinical studies of mental health, aging, substance use, and beyond.

Public health relevance
Project Narrative. We propose to use a combination of large-sample, lifespan functional magnetic resonance imaging (fMRI) data from the Human Connectome Project and advanced statistical modeling to provide (1) optimized methods for estimating the hemodynamic response function (HRF), (2) a large-sample HRF atlas capturing variation across the lifespan, and (3) methods and results estimating a neural connectome after taking the HRF into account. Successful completion of the project will provide more accurate and precise estimates of task-related fMRI activity and brain connectivity in studies of mental health, healthy and pathological aging, substance use, and beyond.